ThermoFisher Scientific Orbitrap Eclipse with ETD and UVPD

Project summary:
This revised proposal seeks funds to acquire a Thermo Orbitrap Eclipse mass spectrometer
equipped with ETD and UVPD to address critical needs for HDX-MS and glycoproteomics studies at
the University of Washington. This system would allow our groups to overcome the technical limitations
and sample analysis bottlenecks that have hindered and stalled many NIH funded projects. The Obitrap
Eclipse platform is the most suitable platform for expanding the projects scopes and throughput of our
HDX-MS studies as it: 1) Offers state of the art sensitivity to lower limits of detection to enable HDX-
MS studies of very material-limited samples, including intact virus particles and hard to purify proteins
from native biological sources; 2) Achieves a mass resolution of 500,000 which is ten times higher than
obtainable on our current instrumentation and is necessary for analyzing highly complex samples; 3) Is
capable of routine and robust high-throughput electron transfer dissociation (ETD), which is vital for
identification of complex protein samples and glycopeptides; 4) Incorporates ultra-violet
photodissociation (UVPD) for expanding the resolution obtainable from HDX-MS studies; and 5)
Enables top-down HDX-MS studies through both ETD and UVPD for proteins refractory to classical
bottom-up approaches. The capacity to combine different fragmentation methods a rapid timescale will
enable development of new tools for site-specific glycoproteomics studies and development of much
needed tools for glycan structural elucidation for glycobiology. This instrument, with its broad
capabilities, will also benefit general proteomics applications and identification of rare and novel post-
translational modifications. While several mass spectrometers are available at UW, all the high-end
systems are heavily utilized and devoted to other applications. The HDX-MS system that is required for
the majority of our users is housed in the School of Pharmacy Mass Spectrometry Center and cannot
be moved and interfaced with the instruments outside of the facility. Additionally, there is not a single
UVPD enabled high resolution mass spectrometer at UW or anywhere in the greater Seattle area to
support out current technological needs. This shared instrument will provide the capabilities and access
needed to advance current NIH funded research and will allow us to push the boundaries of protein
analysis by HDX-MS and site-specific glycoproteomics studies in biomedical research to support future
NIH funded projects.

Public health relevance
Project Narrative: We are requesting funds to purchase a state-of-the-art versatile instrument for structural analyses of complex proteins that cannot be examined by other techniques. These analyses will help improve our understanding of how proteins carry out diverse functions including: how assembly of proteins can lead to various diseases and identify targets to intervene; how viruses recognize and infect our cells and identify ways to block it; how to utilize large protein systems for drug delivery and make better protein- based therapeutics; and identify protein changes that can be used to rapidly diagnose disease progression. All of these areas of research will contribute to biomedical sciences to help prevent and treat human illness.